Regulation of Elevated Postexercise Insulin-stimulated Glucose Uptake by Skeletal Muscle

Over 100 million Americans suffer from the devastating consequences of type 2 diabetes (T2D) or prediabetes
(a condition associated with elevated risk to develop T2D). Skeletal muscle accounts for up to 85% of insulin-
induced blood glucose clearance, and insulin resistance for muscle glucose uptake is an essential, and perhaps
primary defect for T2D. It has been known for 40 years that one exercise bout can enhance subsequent insulin-
stimulated glucose uptake (ISGU) by muscle, but the mechanisms have remained elusive. The long-range goal
is to fully understand the molecular, cellular, and physiological events responsible for this significant health
benefit. Recent research using a unique Akt substrate of 160 kDa-knockout (AS160-KO) rat model revealed that
expression of AS160 (a key regulator of GLUT4 glucose transporter localization) is essential for the elevated
postexercise ISGU. Specific Aim 1 will identify mechanisms whereby AS160 leads to greater postexercise ISGU
by muscle. AS160’s canonical Rab-GAP (Rab-GTPase activating protein) domain controls ISGU under
sedentary conditions. Experiments using AS160-KO rats with AAV-vector (AAV) to deliver AS160 with a mutation
to selectively disable its Rab-GAP domain will test if this domain is required for elevated postexercise ISGU.
Although AS160 expression is essential for elevated postexercise ISGU in both sexes, AS160 phosphorylation
of key sites is required only for male rats. Experiments will test estrogen’s role in the mechanisms responsible
for this important sexual dimorphism. Specific Aim 2 will elucidate the regulation of subcellular GLUT4
localization in skeletal muscle postexercise. Knowledge of AS160’s role in GLUT4 distribution is limited to
insulin’s ability to elevate GLUT4 exocytosis to cell surface membranes in unexercised muscle. A powerful new
microscopy-based approach (STERM, Sample Thinning Enhanced Resolution Microscopy) will examine GLUT4
distribution in 7 different myocellular compartments. Coupling STERM with the AS160-KO model will be used to
test if AS160 is crucial for postexercise regulation of GLUT4 distribution in both cell surface and intracellular
membrane compartments. Specific Aim 3 will ascertain the role of postexercise muscle glycogen resynthesis in
the reversal of the postexercise increase in ISGU. Because the health benefit of elevated postexercise ISGU
could be extended by delaying its reversal, elucidating the mechanism for reversal of elevated ISGU would be
valuable. Experiments will test if muscle glycogen resynthesis is crucial for reversal of elevated postexercise
ISGU by muscle with carbohydrate refeeding. The innovative approach will be to reduce muscle abundance of
glycogen synthase (GS, rate-limiting enzyme for glycogen synthesis) using AAV-vector delivery of shRNA-GS
to muscle. Further analysis will seek to identify mechanisms underlying the relationship between muscle
glycogen and reversal of elevated postexercise ISGU. The research in this project will use rigorous and
innovative methods to enable significant advances in fundamental knowledge and address a critical barrier to
progress in the field by elucidating mechanisms for elevated postexercise ISGU, a major health benefit.

Public health relevance
PROJECT NARRATIVE This research is relevant to public health because insulin resistance for glucose disposal by skeletal muscle is a required defect in the progression to Type 2 diabetes, and exercise can markedly enhance insulin-stimulated glucose uptake by skeletal muscle. We will focus on a protein called AS160 (that regulates glucose uptake), another protein called the GLUT4 glucose transporter (GLUT4 is the protein that is directly responsible for glucose uptake), and a protein called glycogen synthase (that regulates muscle glucose storage in a molecule known as glycogen). This knowledge will advance fundamental understanding of a basic biological outcome, and it has the potential to inform the design of effective exercise protocols and to inspire the creation of new therapies that benefit public health.